RC1 - The Data and Analysis Core (DAC)

PROJECT SUMMARY ABSTRACT – Data and Analysis Core (DAC)
Research on function and disability in vulnerable older adults involves methodological and analytical
challenges. Addressing these challenges often requires specialized expertise and approaches, including
methods for working with data ranging from small, specialized datasets to complex national datasets;
developing tailored approaches to analyzing longitudinal, repeated measures; managing complex and
informative missing data mechanisms; addressing competing risks; and controlling for multilayered
confounding in predictor-outcome relationships. It also requires a deep understanding of measurement,
including the many ways in which disability and function can be measured and how these measures relate to
underlying constructs of function and disability. The Data and Analysis Core (DAC) will build upon its history of
success by serving as a hub of expertise and support in these areas and assisting the research design and
analytic needs of OAIC-affiliated investigators. We will focus on two areas that have emerged as central pillars
of our past successes. First, we aim to provide world-class statistical and methodologic consultation and direct
analytic support to OAIC-affiliated investigators, with a major focus on study design, measurement, and the
special analytic considerations that arise in quantitative studies of function and disability in vulnerable older
adults. Second, we will provide expert consultation and direct support for secondary data analysis studies
using high-value national datasets including the Health and Retirement Study (HRS), National Health and
Aging Trends Study (NHATS), national Medicare data including the Minimum Data Set (MDS), and national VA
data. In addition to continuing our established programs in these areas, we seek to innovate and grow to
address the evolving landscape of aging research and the needs of investigators working in this field. Areas of
growth include enhanced focus on thoughtfully addressing race, ethnicity, and other important socioeconomic
features in study focus, design, and analyses; expanding opportunities to incorporate physical performance,
biomarker, and genetic data into research using high-value datasets such as the Health and Retirement Study;
expanding capacity for analysis of national Medicare data and of UCSF electronic health record data; and
addressing important opportunities and analytic challenges that have arisen from the COVID pandemic.
Our specific aims are: (1) To provide statistical consultation and direct analytic support for OAIC-affiliated
research, particularly for pilot, research career development, External Project, and Development Project
investigators; (2) To provide consultation on study design and measurement issues for OAIC-affiliated
research, particularly for pilot, research career development, External Project, and Development Project
investigators; (3) To promote and support research on function and disability using high-value national
datasets; and (4) To support Development Projects that conduct novel methodologic research that advances
the science of studying function and disability in vulnerable older adults.